Cancer Research Training and Education Coordination

PROJECT SUMMARY – Cancer Research Training and Education Coordination (CRTEC)
Education and training have been central to the mission of the Abramson Cancer Center (ACC) throughout its
existence. The ACC Cancer Research Training and Education Coordination (CRTEC) component coordinates
ACC cancer-related education, training, and career activities. In this role, CRTEC integrates these activities
across the Penn campus, including the ACC, the Perelman School of Medicine (PSOM), and nine other Penn
Schools that have activities with cancer education and training content. A prime focus of CRTEC is to drive and
promote cancer education and training activities in the ACC and across the University of Pennsylvania with the
goals of delivering cancer-related education to students, trainees, faculty, and other professionals and
expanding and diversifying the cancer workforce through targeted education, training, and mentorship. The
Specific Aims of CRTEC are as follows: Aim 1: Coordinate cancer education, training, and career development
activities across the ACC and Penn; Aim 2: Provide cancer research-related education, training, and
mentorship to individuals ranging from high school and undergraduate students to cancer professionals, with
an emphasis on ensuring a diverse and enduring pipeline of trainees and future cancer researchers; and Aim
3: Evaluate the quality and impact of ACC CRTEC activities to improve ACC education/training and to guide
new CRTEC developments. CRTEC impacts students, trainees, and professionals with a goal to advance
cancer research careers starting with entry-level professional training through faculty and cancer research
leadership roles. CRTEC is led by an ACC Associate Director for Education and Training, senior support staff,
and an Operations Committee. It interacts with the Programs, Shared Resources, and Community Outreach
and Engagement. CRTEC impacts the ACC by (1) coordinating the already diverse, well-established, and
extensive cancer-related education and training activities at the ACC and Penn; (2) improving access to
cancer-related education for students, trainees, staff, and professionals; (3) sustaining cancer career
development through integrated cancer-related training and mentoring for faculty, trainees, and staff; and (4)
enhancing diversity at all levels of education and training. CRTEC leverages formidable strengths at ACC and
Penn in cancer education and training that include a compact, accessible, and highly integrated campus with
extraordinary depth in all disciplines relevant to cancer research; longstanding cancer-focused education in the
ACC, PSOM and other Schools; a uniquely large and diverse portfolio of GME and biomedical postdoctoral
training programs, many with decades of NCI and other funding; extensive ACC-directed professional
education; and expertise and national leadership in basic, translational, clinical, and population-based cancer
research. CRTEC provides ACC members with a central point of contact for innovations in cancer-related
education and training.